Repurposing Mycobacterium tuberculosis tRNase toxins for cancer chemotherapy

Project Summary
The genome of the bacterium that causes tuberculosis, Mycobacterium tuberculosis (Mtb), harbors an
astonishingly large number of specialized growth regulating toxins. We and others have discovered that many
of these Mtb toxins are highly selective tRNases with properties that make them attractive candidates for cancer
treatment on their own or as protein-conjugated immunoRNases. There is one RNase to go into clinical trials for
treatment of cancer, Onconase. However, the Mtb tRNase toxins have much higher intrinsic specificity than the
poorly characterized enzymatic activity of Onconase. The unprecedented target selectivity of these Mtb tRNase
toxins is important because earlier tRNA microarray expression studies revealed significant increases in a few
functional, full length tRNAs in patient-derived breast tumor samples. These tRNA species are thought to be
upregulated in order to accommodate higher demand when cells are reprogrammed to produce one or more
cancer-promoting proteins rich in this particular amino acid. Therefore, Mtb tRNase toxins constitute a large new
untapped reservoir of highly specialized tRNases, each endowed with the ability to recognize a single tRNA as
substrate. In this exploratory R21 proposal in response to FOA PAR-19-194 Microbial-based Cancer Therapy -
Bugs as Drugs, we hypothesize that these specialized toxins can ultimately be exploited for cancer treatment
because they are predicted to cleave and disable tRNAs required for efficient translation of pro-oncogenic
proteins. The three specific Aims define the specificity of six of these tRNase toxins in human breast cancer cell
lines and tissues.

Public health relevance
Narrative Breast cancer is the second leading cause of cancer deaths in women. Although death rates have been gradually decreasing for women over 50, they remain steady for those under 50 because many in this group have triple- negative breast cancer. This exploratory R21 proposal in response to FOA PAR-19-194 Microbial-based Cancer Therapy - Bugs as Drugs proposes pilot experiments for an innovative approach to treatment that enlists highly selective Mycobacterium tuberculosis toxins with the long term goal of enhancing breast cancer survival.